The impact of Left Ventricular Assist Device Implantation on Cerebral Hemodynamics and Cognition

PROJECT SUMMARY
The left ventricular assist device (LVAD) has revolutionized care for patients with advanced heart failure, but the
impact on cerebral hemodynamics is poorly understood and represents an opportunity to optimize outcomes for
this challenging patient population. Given organ scarcity and advances in LVAD technology, the majority of
LVADs are now implanted as destination therapy. Neurologic complications have long been respected as the
most significant contributor to bad clinical outcomes. Suboptimal brain perfusion increases the risk of stroke,
cognitive decline, and brain atrophy, all of which are critical concerns in this patient population. Unfortunately,
cerebral blood flow is not measured in routine clinical care, so it is not directly considered in LVAD management.
In clarifying the relationship between LVAD physiology and neurovascular health, this proposal will identify
hemodynamic metrics that will ultimately provide treatment targets by which we can personalize and improve
long-term outcomes.
Quantifying cerebral hemodynamics represents a significant challenge because LVADs are not MRI compatible.
Other advanced imaging technique, including PET or CT provide only a snapshot in time. Transcranial Doppler
ultrasonography is particularly well suited for this clinical scenario because it provides a continuous, non-invasive
measure of cerebral blood flow (CBF) at the bedside. Though transcranial Doppler probes large trunk vessels,
waveform morphologic features are informative of microvascular function, and these CBF data be leveraged to
quantify two critical measures of cerebrovascular health: cerebral autoregulation and cerebrovascular reactivity.
Autoregulation describes the relationship between blood pressure and CBF, while cerebrovascular reactivity
quantifies the ability to augment CBF in times of demand. Both metrics are impaired in advanced heart failure
and predict stroke risk and cognitive decline across a range of disease states. Our group recently reported
improvement in autoregulation and cerebrovascular reactivity after LVAD implantation. The objective of this
proposal is to build upon our recent studies to establish the relationship between LVAD and cerebral
hemodynamics in long-term follow-up, correlating with cognition and brain atrophy over time.
In clinical practice, LVAD speed and medication regimens are titrated to optimize cardiopulmonary
hemodynamics and target a mean arterial blood pressure <90 mmHg. Our group recently demonstrated the
sensitivity of CBF to LVAD pump speed, so with this proposal we will systematically explore the sensitivity of
cerebral hemodynamic metrics to LVAD parameters by performing CBF monitoring during speed titration. Taken
together, this proposal will reveal future opportunities to leverage cerebral hemodynamic metrics as treatment
targets in long-term LVAD care, with the goal of optimizing neurologic outcomes.

Public health relevance
PROJECT NARRATIVE With advances in left ventricular assist device technology there is a rapidly growing and aging patient population for whom brain health is paramount to long-term functional outcome. The impact of device implantation on cerebral hemodynamics represents both a significant knowledge gap and an opportunity to optimize clinical outcomes. This proposal will establish the relationship between left ventricular assist device implantation and cerebral hemodynamics in long-term follow-up while accounting for clinically relevant neurologic outcomes such stroke, cognitive decline, and brain atrophy.